Mechanisms Regulating Chromatin Organization and Epigenetic Memory

SUMMARY
Upon fertilization, the zygotic genome is dramatically remodeled to achieve a transient totipotent state that is
necessary to lay the foundation for embryonic development and differentiation. Activation of the genome
requires choreographed contacts between enhancers and promoters. Mutations in the genes that encode the
machinery required to orchestrate this remodeling and contact are causative of numerous developmental
syndromes or embryonic lethality. Despite its unequivocal importance for child development, reproduction
and fertility, the relationship between chromatin structure and enhancer-promoter communication that
underpins correct developmental programming remains poorly understood, particularly in vertebrates. In
addition, the factors and motifs that mediate these structures and gene regulatory communication, including
their specific functions, have not been extensively studied. A major barrier to understanding these
relationships in the dynamic system of a developing vertebrate has been a dearth of suitable approaches that
can achieve genome-wide and high-resolution information given the limitations in input material. To overcome
these limitations, in our preliminary studies we have optimized techniques to detect novel regulatory factors
and chromatin structures with unprecedented resolution in zebrafish embryos. In addition, our recently
developed expansion microscopy technique now allows us to address fundamental questions about how
enhancers and promoters interact and transmit information at nucleosome resolution. The confluence of
development of these techniques now allows us to investigate the molecular mechanisms that regulate
genome activation and gene expression in a dynamic vertebrate system. Using these approaches, we aim to
understand how specific factors contribute to the establishment of the 3D genome architecture as well as
investigate a mechanism for explaining how transient genomic contacts can propagate longer-term regulatory
information (Aim 1), and identify the repertoire of regulatory elements that mediate enhancer-promoter
interactions as well as the factors and their motifs that regulate gene expression (Aim 2). By defining the
regulatory grammar and mechanisms guiding genome activation in the zebrafish embryo, this work will fill
critical gaps in our knowledge of gene regulation in a dynamic developing system, and provide valuable
insights with broad implications for developmental biology, epigenetics, and reproductive medicine.

Public health relevance
NARRATIVE Proper regulation of gene expression is critical for embryonic development. This proposal aims to understand how the structure of the genome and histone modification transmit regulatory information between enhancers and promoters, and to identify the factors that mediate this communication to ensure precise gene regulation.